Effects of parents' participation in public work programs on children's health and education in select low- and middle-income countries

Abstract (30 lines):
Public Work Programs (PWPs) are implemented in over 60 low-and-middle-income countries (LMICs). They
are designed to address the immediate needs arising from poverty by providing temporary cash-for-work
opportunities to boost poor households’ incomes as well as provide new or improved infrastructure to local
communities. There is growing evidence of the short-run impacts of PWPs on adult beneficiaries during
program exposure and medium-run impacts when the PWPs are no longer available. However, there is
surprisingly no experimental evidence on the impacts of PWPs on children living in beneficiary households at
the time of exposure. The first part of the proposed project will leverage existing data on approximately 12,000
households from six large-scale public-works experiments conducted by the PI in Sub-Saharan Africa and the
Middle East and North Africa regions to estimate the short-run impacts of households’ exposure to PWPs on
household-level measures of children’s education and labor activities. The second part of the project will
collect new data on physical health, cognitive and non-cognitive skills, labor activities, and time-use from all six
sites to estimate the medium-run impacts of households’ exposures to PWPs during two important life-cycle
stages: (a) early-childhood (i.e., those exposed to public works during in utero-5 years), and (b) school-ages
(i.e., those exposed to public works between 6 and 14 years). The medium-run effects of PWPs are expected
to vary between the early-childhood and school-age cohorts. For younger children, adults’ access to cash-for-
work may facilitate important and timely investments in antenatal care and nutrition during sensitive periods of
growth. It may attenuate the effects of early childhood nutritional deficiencies and improve children’s health and
cognition in a permanent way. However, an increase in cash-for-work opportunities often reduces adults’ time
at home and the family business. Importantly, for school-age children, the effect of PWPs can be ambiguous
as the income and substitution effects of public-works impact children’s human capital in opposite ways. The
income effect of public works encourages greater investments in health and schooling inputs. At the same
time, the burden of substituting for parental and other adults’ activities at home and at work can reduce school-
age children’s time in school, which may adversely affect their human-capital outcomes. This project will be
the first to exploit experimental variation in access to public-works opportunities to estimate the short-
and medium-run impacts of households’ exposures to PWPs during important childhood life-cycle
stages on human capital and related outcomes.

Public health relevance
Project Narrative (3 sentences) Failure to reach one’s potential in health, cognition, and socioemotional development during early childhood and school ages has both short-run consequences in terms of poor health, cognition, and socioemotional development and significant long-term consequences in terms of reduced socioeconomic well-being over one’s life course. The findings from this project will provide rigorous evidence on the role of public-works programs in addressing poverty-led growth failures for preschool and school-age children. The findings that emerge from analyzing causal evidence on the short- and medium-run impacts of households’ exposures to public works on children, during two important life-cycle stages from different demographic, cultural, and institutional contexts in Sub-Saharan Africa and the Middle East and North Africa regions will provide critical evidence that can inform social-protection policymaking in LMICs.